Mitochondrial metabolic regulation of lung epithelium: alveolar generation and regeneration

Project Summary/Abstract
This application for a Mentored Clinical Scientist Research Career Development Award (K08) is being submitted
by SeungHye Han, MD, MPH, and entitled “Mitochondrial metabolic regulation of lung epithelium: alveolar
generation and regeneration.” I am a pulmonary and critical care physician at Northwestern University who is
obtaining additional training to build expertise as a physician scientist studying metabolic regulation of lung
development and repair after lung injury. My long-term research goal is to find new therapeutic targets to promote
lung repair in patients with acute respiratory distress syndrome (ARDS). The objective of my current project is to
study the role of mitochondrial complex I on postnatal lung development and lung repair after influenza infection,
and identify metabolites and pathways that link complex I driven respiration to lung stem/progenitor cells.
ARDS is a devastating disorder commonly associated with pneumonia and influenza infection, which are
categorized as one of the ten leading causes of death in the United States. The mortality rate is high from 30 to
45%, and there is no current effective therapy except supportive care. One novel therapeutic approach is to
promote lung repair after injury has occurred. Several lung epithelial subpopulations have been reported to
expand in response to various insults, and repopulate to replace damaged alveolar epithelial cells. Little is known
about how proliferation and differentiation are regulated in these epithelial stem/progenitor cells. My mentor Dr.
Chandel’s laboratory previously demonstrated that the mitochondrial respiratory chain is essential for the
differentiation of various cells including keratinocytes, adipocytes, and hematopoietic stem cells. These effects
are exerted through reactive oxygen species or the accumulation of mitochondrial metabolites that control
epigenetic machinery, and are independent of the ATP synthetic function of mitochondria. Whether lung epithelial
stem/progenitor cells are regulated by mitochondrial metabolism has not been studied. My preliminary data
suggest that mitochondrial complex I driven respiration is required for the differentiation of lung epithelial
stem/progenitor cells. These observations led to the novel hypothesis that mitochondrial complex I driven
respiration, independent of ATP generation, is necessary and sufficient for postnatal lung development via
metabolites (Aim 1), and is necessary for the repair of influenza-induced adult epithelial lung injury (Aim 2).
My project will provide a new mechanistic model linking mitochondrial metabolism to lung epithelial
stem/progenitor cells in the context of lung injury and repair. The training plan will promote acquisition of key
metabolic and biochemical laboratory skills, proficiency with conducting animal studies, and interpretation of high
throughput data from high dimensional (-omic) platforms. The activities planned in this proposal, including
guidance with close mentorship, attendance of conferences, and completion of coursework in a research-
intensive institutional environment, will further my continued development into an independent researcher.

Public health relevance
Project Narrative The acute respiratory distress syndrome (ARDS) is a life-threatening lung condition, leading to low oxygen levels in blood, that commonly develops after pneumonia and influenza infections. Scientists have recently discovered that mitochondria, small organelles in most living cells that were previously known for energy generation, actually play a role in regulating how stem cells develop into different cell types. This study seeks to better understand the mechanisms behind how mitochondria influence stem cells and their differentiation in the lungs, and eventually lead to new therapies to promote repair in lung tissue damaged by ARDS.